Oncogenic role of the ICK-GSK3beta signaling pathway

? DESCRIPTION (provided by applicant): Colorectal cancer (CRC) is the third most common malignancy and fourth most common cause of mortality worldwide, and there is an urgent need of new therapeutic approaches for this devastating disease. Although many signaling pathways with important roles in CRC have been identified, there are still major gaps in our understanding about how these pathways functionally network and interplay during malignant transformation of the intestinal epithelium. Our long-term goal is to identify key missing components in this complex signaling puzzle to advance our understanding of the molecular mechanism underlying colon cancer. The objective of this proposal is to explore the role of a novel signaling pathway ICK-GSK3β in the development of colon cancer and tumor resistance to rapalogs. Our central hypothesis is that deregulated ICK-GSK3β signaling axis plays a pivotal role in intestinal neoplasia by transducing aberrant Wnt signals to mTOR hyper-activation through inhibitory phosphorylation of GSK3β-T7 and by mediating a novel feedback mechanism underlying rapamycin resistance in colon cancer therapy. This hypothesis was formulated on the basis of our recent published and preliminary data: 1) ICK, a Wnt transcriptional target, is highly over-expressed in human colon cancer specimens and mouse intestinal adenomas; 2) Knockdown of ICK expression in human colon cancer cells effectively attenuated malignant proliferation in vitro and subcutaneous tumor growth in vivo; 3) Disrupting ICK signaling in colon cancer cells impaired mTOR and Wnt activation; 4) GSK3β, a key component of both Wnt and mTOR pathways, is a novel substrate for ICK; 5) Elevated phosphorylation of GSK3β-T7 by ICK was observed in human CRC specimens as compared with adjacent normal mucosa and in human colon cancer cells after rapamycin treatment. To test this hypothesis, we propose the following two specific aims: Aim-1 will determine whether ICK is able to activate mTOR signaling in colon cancer cells through targeting a novel inhibitory phosphorylation site on GSK3β; Aim-2 will determine whether the ICK-GSK3β signaling axis is important for aberrant Wnt signal-induced intestinal malignancy and rapamycin resistance. Our proposed work is significant because our aims will address major knowledge gaps in our understanding of the mechanisms underlying Wnt activation of mTOR, inhibitory phosphorylation and regulation of GSK3β, and rapamycin resistance. Our proposed work is innovative because our aims may identify inhibitory phosphorylation of Thr-7 as a novel regulatory mechanism for GSK3β, and rapamycin-induced feedback up-regulation of GSK3β-T7 phosphorylation as an innovative mechanism underlying rapamycin resistance. Anticipated outcomes may exert significant impacts on the understanding of the signaling mechanisms underlying the onset and development of colon cancer as well as the design for more effective combination molecular therapy to overcome drug resistance and prevent tumor relapse.

Public health relevance
PUBLIC HEALTH RELEVANCE Elucidating the critical missing components of key signaling pathways of Wnt and mTOR and their interplays during neoplastic transformation of the intestinal epithelium is essential for identifying new therapeutic targets to improve the diagnosis, intervention, and treatment of colon cancer. Our newly-identified ICK-GSK3β signaling axis may contribute significantly to the development of colon cancer and tumor resistance to rapalogs. The outcomes from this study may significantly advance our understanding of the current paradigm for intestinal carcinogenesis and offer novel drug target candidates that help to overcome drug resistance for more effective colon cancer therapy.